DEVELOPING PATIENT EDUCATION MATERIALS TO ADDRESS THE NEEDS OF PATIENTS WITH SENSORY DISABILITIES

DEVELOPING PATIENT EDUCATION MATERIALS TO ADDRESS THE NEEDS OF PATIENTS WITH
SENSORY DISABILITIES
There are at least 16.2 million adults who identify as being deaf or hard-of-hearing (DHH) and 12.8 million
who report significant vision difficulty (i.e., blind/vision impairment [B/VI]). People with sensory disabilities
(PWSDs) are a growing priority population due to significant health disparities, including poorer mental
health and physical health. Despite poorer health, PWSDs struggle with unmet medical needs, difficulties
accessing and navigating health care and challenges with managing their health. Health education and
promotion programs, including consumer health information resources, are often inaccessible and not
tailored for these individuals, exacerbating above inequities. In addition, accessible health resources, such
as ASL videos on “DeafHealth.org” and MedlinePlus, are no longer available. Prior research indicates that
PWSDs are at risk for inadequate health literacy, poorer access to information resources, and disparities
in advance care planning and diabetes prevention and management. Therefore, the primary objective of
this NLM G08 information resource proposal is to develop best practices in digital and non -digital patient
health education for PWSDs and demonstrate these best practices in use by developing materials on
advance care planning and diabetes prevention. This will be accomplished through three aims. (1) Assess
the information and accessibility needs of PWSDs to identify optimal user-centered design for patient
health education; (2) Develop patient health education assessment checklists centering the needs of
PWSDs; and (3) Demonstrate the utility of the checklists as guides in the development and curation of
accessible patient health education for PWSDs focused on advance care planning and diabetes . To guide
the above work, an Advisory Board of patients with sensory disabilities and librarians with or serving those
with sensory disabilities will be convened. Representatives on this Advisory Board will advise the project
team, provide expertise on centering the accessibility needs of people with sensory disabilities, and assist
with review of materials. This information will be used to generate a checklist and practice
recommendations for health educational programs and information resource developers in order to meet
the unique health educational needs of PWSD experiencing health disparities and comply with disability
based civil rights laws (Section 504 of the Rehabilitation Act of 1973, which covers federally funded
programs; the 1990 Americans with Disabilities Act (ADA) and 2008 ADA Amendments Act; and Section
1557 and other provisions of the 2010 Patient Protection and Affordable Care Act) that mandate
accessible health education materials.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH SIGNIFICANCE) People with sensory disabilities – such as people who are deaf, blind, or DeafBlind – are an overlooked population with significant health inequities due to inaccessible healthcare and health information resources. Despite this gap, few patient health education materials are designed with their information and accessibility needs in mind. The purpose of this proposed study is to (1) conduct surveys and focus groups with people with sensory disabilities to understand their health information needs, (2) develop an evidence-based checklist for patient health education material developers to use to meet these needs, and (3) create and curate publicly available digital content to improve advanced care planning and diabetes prevention among people with sensory disabilities.